Deep Fractions Learning: A Core Curriculum of Games, Inquiry, and Collaboration

Project? ?Summary/Abstract There? ?is? ?an? ?enormous? ?deficit? ?in? ?students?? ?understanding? ?of? ?fractions? ?in? ?the? ?United? ?States. Fifth? ?grade? ?fraction? ?knowledge? ?predicts? ?high? ?school? ?math? ?performance,? ?even? ?when? ?controlling for? ?working? ?memory,? ?whole? ?number? ?knowledge,? ?IQ,? ?reading? ?ability,? ?and? ?demographic? ?factors (Siegler? ?et? ?al.,? ?2012).? ?Therefore,? ?addressing? ?this? ?deficit? ?is? ?a? ?particularly? ?important? ?area? ?for? ?early intervention.? ?With? ?this? ?Fast-Track? ?grant,? ??Deep? ?Fractions? ?Learning?,? ?we? ?propose? ?to? ?transform? ?the way? ?in? ?which? ?students? ?learn? ?core? ?math? ?curriculum? ?so? ?that? ?materials? ?are? ?more? ?interactive? ?and engaging,? ?promote? ?deeper? ?learning? ?of? ?content,? ?and? ?are? ?aligned? ?with? ?the? ?Common? ?Core.? ?More specifically,? ?we? ?will? ?develop? ?and? ?evaluate? ?a? ?digital? ?curriculum? ?for? ?grades? ?3-5? ?covering? ?the fractions? ?domain? ?that? ?combines? ?games,? ?collaboration,? ?and? ?an? ?inquiry? ?approach.? ?We? ?propose? ?to develop? ?an? ?innovative? ?technology? ?infrastructure? ?that? ?will? ?integrate? ?Teachley? ?learning? ?games, Success? ?for? ?All?s? ?(SFA)? ?cooperative? ?learning? ?framework,? ?and? ?rigorous? ?lesson? ?content.? ?We? ?will integrate? ?research? ?into? ?the? ?design? ?process? ?and? ?work? ?with? ?Johns? ?Hopkins? ?University? ?to? ?evaluate the? ?efficacy? ?of? ?the? ?intervention. Outcomes.? ??The? ?intervention? ?will? ?encourage? ?four? ?direct? ?outcomes? ?for? ?students,? ?namely improved:? ?1)? ?conceptual? ?understanding? ?of? ?fractions,? ?2)? ?procedural? ?fluency? ?with? ?fractions operations,? ?3)? ?mathematical? ?justification,? ?and? ?4)? ?motivation.? ?First,? ?the? ?curriculum? ?will? ?build? ?both conceptual? ?understanding? ?and? ?procedural? ?fluency,? ?providing? ?strong? ?visual? ?models? ?within engaging? ?games? ?that? ?motivate? ?students? ?to? ?practice.? ?The? ?collaborative? ?learning? ?model? ?and? ?inquiry approach?? ??will? ?improve? ?students?? ?mathematical? ?justification.? ?Finally,? ?we? ?encourage? ?these outcomes? ?within? ?a? ?motivational? ?support? ?structure? ?designed? ?to? ?foster? ?engagement? ?and self-efficacy. Improving? ?students?? ?academic? ?outcomes? ?and? ?self-efficacy? ?in? ?the? ?area? ?of? ?fractions? ?during elementary? ?school? ?will? ?promote? ?later? ?success? ?in? ?high? ?school? ?mathematics.? ?Since? ?each? ?additional math? ?class? ?students? ?complete? ?in? ?high? ?school? ?more? ?than? ?doubles? ?the? ?odds? ?of? ?college? ?completion (Adelman,? ?2006),? ?the? ?intervention? ?has? ?the? ?potential? ?to? ?make? ?a? ?real? ?difference? ?in? ?whether students? ?achieve? ?sustainable? ?careers? ?versus? ?being? ?stuck? ?in? ?low-wage? ?jobs.

Public health relevance
Project Narrative Fractions knowledge in the fifth grade strongly predicts high school math performance, even when controlling for working memory, whole number knowledge, IQ, reading ability, and demographic factors (Siegler et al., 2012). Intervention in this essential content area will improve students’ math ability in the short and long term, which in turn will lead to several positive distal outcomes, such as greater high school graduation rates and college attendance.